A New Immune Checkpoint Pathway in Human Bladder Cancer

A new immune checkpoint pathway in human bladder cancer
This proposal is in response to the PAR-19-183 (Biology of Bladder Cancer).
Bladder cancer is one of the most common malignancies in the United States.
The survival rate of bladder cancer has been largely unchanged for the last 30
years. Very recently PD-1/PD-L1 inhibitors were approved by FDA for the
treatment of patients with metastatic bladder cancer, but worked in only a subset
of ~15-25% of patients. Thus, there is a pressing need to develop new and
effective treatment for bladder cancer. Developing novel checkpoint inhibitors,
especially inhibitors that target outside the PD1/PD-L1 and CTLA-4 pathways, is
a promising strategy and may potentially have high impact in clinical
management of human bladder cancer. Our central hypothesis of this proposal is
that KIR3DL3-HHLA2 is a previously unrecognized immunosuppressive pathway
as well as a novel therapeutic target in human bladder cancer. Guided by our
published clinical and basic research and our strong preliminary data, we will
pursue following specific aims: 1) Investigate the cellular and molecular
mechanisms of HHLA2 expression in human bladder cancer and APCs; 2)
Dissect co-inhibitory function and signaling of the KIR3DL3-HHLA2 pathway; and
3) Develop new immunotherapies against human bladder cancer by targeting the
KIR3DL3-HHLA2 pathway. This proposal comprises an integrated network of
multi-disciplinary collaborative investigators (immunologists, urologists,
oncologists, and bioinformaticians) to accelerate translational research and
maximize future clinical benefits. The outcomes of this project will reveal new
fundamental biology of human bladder cancer and will guide the rational
development of new immunotherapies for the treatment of human bladder
cancer.

Public health relevance
The proposed research is directly relevant to public health and NIH’s mission, because our program will result in new functional and mechanistic understanding of a new immune checkpoint pathway in human bladder cancer. This new insight will directly translate into novel immunotherapies for the treatment of human bladder cancer.